Near Infrared Light Activated Adhesives for Nerve Repair

SUMMARY
Nerve damage from trauma including combat, accidents, sports injuries, and neuropathies, affects over 350,000
patients annually in the U.S. resulting in loss of sensation, chronic pain, and sometimes permanent disability.
Surgery is generally required for in case of peripheral nerve injury because of the slow rate of repair and
regeneration. Nerve repair generally involves direct approximation of the severed nerves for small gaps and
placement of allografts of synthetic grafts to facilitate nerve regeneration for large nerve gaps. Suturing is the
clinical standard for nerve repair and involves apposition of the outermost layer or epineurium under a surgical
microscope. Epineural suturing is time consuming, requires significant skill, and can result in chronic
inflammation, fibrosis, and asymmetrical tension. Existing glues typically do not provide significant added benefit
and suffer from weaker mechanical properties and complexities in application. Reduction in procedure times,
generation of minimal-tension approximation, and prevention of scar formation are critical for improving repair
outcomes and costs in peripheral nerve injuries. In this research, we will develop novel formulations of near
infrared light activable adhesives (NILAAs) for rapid epineural sealing and subsequent nerve repair. A set of
NILAA biomaterials will be generated and characterized for their rheological and mechanical properties. The
response of NILAA biomaterials to different wavelengths and power intensities of near infrared light will be
determined and optimal sealing conditions will be identified using a mathematical model in concert with thermal
imaging. NILAAs that demonstrate effective ex vivo sealing will be used to determine efficacy of nerve repair in
a sciatic injury model in rats. NILAAs will be used as glues to seal small gaps i.e. transverse incision and as
tapes or wraps to secure synthetic regenerative conduits in large (1 cm) defects in the sciatic nerve in Sprague
Dawley rats. Muscle electromyographic (EMG) response, biomechanical recovery, and cellular and biochemical
responses will be determined for nerves sealed and repaired using NILAAs, and their performance will be
compared to sutures and glues. A combination approach of sutures with NILAAs will also be investigated for
facilitating nerve repair. We propose that NILAAs are innovative approach for epineural sealing, repair and
regeneration of small as well as large nerve defects leading to faster operation times and better quality of repair
including low trauma, scarring, and inflammation, which make this technology highly attractive for clinical
translation.

Public health relevance
Narrative Nerve damage from trauma affects over 350,000 patients annually and causes loss of sensation, function, pain and even permanent disability. Suturing is the clinical standard for nerve apposition (approximation of nerves) but can cause inflammation, fibrosis, asymmetric tension, and is time-consuming. We propose the development of novel near infrared light activable adhesives (NILAAs) for sutureless approximation of peripheral nerves, leading to rapid repair and regeneration of small and large defects following injury.